Admin-Core-001

ABSTRACT – Administrative Core
The Administrative Core will coordinate and oversee this Program Project Grant entitled “Immunologic and
Virologic Determinants of Congenital CMV Transmission”, providing scientific and administrative oversight and
management to the Projects and Cores to ensure that the activities synergize between the host institutions. In
particular, the Administrative Core will support the scientific Projects and Cores in making steady progress
toward meeting project milestones. Additionally, the core will plan biweekly and monthly teleconference
meetings with scientific leadership and primate centers and annual scientific leadership group meetings, which
will alternate between Duke University and the location of the biannual International CMV Meeting. Also
participating in the annual meeting and providing guidance to the Program is an External Advisory Board,
composed of members with expertise in HCMV vaccine development, HCMV/RhCMV pathogenesis, HCMV
immunology, and RhCMV/HCMV-vectored vaccines. Finally, the Administrative Core will manage funds, plan
the agenda for internal scientific meetings, prepare periodic progress and research reports and assistance with
related manuscripts, as well as ensure fiscal responsibility and compliance with all institutional and federal
guidelines. In sum, the Administrative Core will coordinate collaboration, thereby promoting the overall success
of this unified research effort.